RNA-mediated Chromatin Regulation and Transgenerational Epigenetic Inheritance in C. elegans

Project Summary/Abstract:
Nuclear RNAi is an evolutionarily conserved epigenetic silencing pathway that targets transposons and other
foreign DNA. The defining features of this pathway are small RNA-guided chromatin modifications and
transcriptional repression at a target gene. In C. elegans, nuclear RNAi is essential for genome stability and
promotes germline immortality. Nuclear RNAi can be conveniently triggered by feeding worms with dsRNA,
which leads to heritable silencing at the target gene for multiple generations. These features, together with
powerful genetics and genomic tools and a three-day reproductive cycle, make C. elegans a highly tractable
system to study transgenerational epigenetic inheritance (TEI) in animals. Project 1. Investigating the
biochemistry and cellular function of a novel histone modification H3K23me3. The broad and long-term
objectives of this project are to comprehensively identify and characterize the histone post-translational
modifications and corresponding chromatin enzymes in the context of TEI. In the proposed funding cycle, this
application will investigate the function and enzymology of a novel histone modification H3K23me3, which can
be induced by nuclear RNAi. H3K23me3 is an understudied heterochromatin mark even though it is conserved
from plants to mammals. This application will take combined genetic, genomic, and biochemical approaches to
(1) determine the functional relationship between three key heterochromatin marks: H3K9me3, H3K23me3,
and H3K27me3, (2) understand why the nuclear RNAi pathway is required for C. elegans germline immortality
under heat stress, and (3) identify additional H3K23 histone methyltransferases in C. elegans. The results will
advance the histone code theory and provide mechanistic insight into nuclear RNAi and TEI. Project 2.
Investigating how C. elegans germline distinguishes self and nonself siRNAs. The broad and long-term
objectives of this project are to dissect the diverse functions of small RNAs in C. elegans and understand how
cells distinguish self and foreign genetic material. As a short-term goal, this project will investigate a newly
identified genetic activity termed “siRNA suppression”, which enables C. elegans to distinguish siRNAs that
target self-genes from ones that target nonself DNA such transposons. Both classes of siRNAs play important
but different functions in animal development. This project will identify the protein factors, subcellular location,
and molecular rules of siRNA suppression. As an overall significance, this application will identify new
components in chromatin and small RNA, both of which are fundamental to our understanding of
transgenerational epigenetics and long-term environmental impacts on human health.

Public health relevance
Project Narrative: RNA-mediated chromatin regulation and transgenerational epigenetic inheritance hold profound implications in genome-environment interaction and inheritance of gene activities relevant to development, aging, and disease. Using C. elegans as a model organism, our short-term research plan will characterize a new chromatin structure and a new mode of siRNA regulation that we have recently identified. The proposed work will provide both conceptual and experimental frameworks towards our long-term goal of exploring the channels and barriers of transgenerational epigenetic inheritance.